G-RISE at The City College of New York

The rationale for the proposed G-RISE project begins with the need for a well-trained biomedical research
workforce and the gains to be achieved by improving its diversity. Our position of research strength in the
biomedical sciences, within a large public university in the heart of an underserved community, gives us
both the motivation and the ability to cogently address these needs. In this project, a group of 22 faculty
members at The City College of New York (CCNY) will build on the success of a prior RISE program to
offer coordinated, innovative, and rigorous Ph.D. training in biochemistry, biophysics, bioorganic
chemistry, (biomedical and chemical) engineering, and neuroscience. The proposed program has the
capacity to support an average cohort of 13 underrepresented (UR) Ph.D. trainees each year for five years,
appointing each trainee for 2-3 years. The broad mission of the proposed program is to focus research and
professional skills development on underrepresented Ph.D. trainees at CCNY while also providing
beneficial impact for our broader population of trainees and mentors in STEM disciplines. Our specific
objectives and strategies are as follows:
· To recruit and retain talented minority Ph.D. trainees whose biomedical research interests align
with the participating CCNY faculty-led teams. Vigorous recruitment will be coupled with
sustained mentee-mentor matching, development of sound cohort and research identity, and
provision of a supportive and inclusive training environment.
· To offer rigorous didactic training that combines disciplinary depth with interdisciplinary breadth
while progressively building independent research design skills. Interdisciplinary degree tracks
and co-teaching will be emphasized.
· To provide robust research training that fosters individual skills and creativity, cooperation within
a research group, synergy among research groups, and the use of state-of-the-art technology to
address important open issues in the biomedical sciences.
· To offer structured research-related activities that build STEM research identity and ethical values,
an inclusive and supportive G-RISE cohort, career-ready skill sets and focus.
· To achieve trainee outcomes that include enhanced numbers and proportions of UR Ph.D.’s who
achieve timely graduation in biomedical science and engineering disciplines, while also improving
each trainee’s technical and communication skills, research productivity, and post-Ph.D. placement
in the workforce.
In the proposed project, a strategic combination of NIH and institutional resources will allow us to improve
the reach and rigor of biomedical research training at CUNY’s City College of New York.

Public health relevance
Project Narrative A group of 22 faculty researchers at The City College of New York (CCNY) proposes to leverage a position of research strength in the biomedical sciences, within a large public university in the heart of an underserved community, to address the need for a well-trained biomedical research workforce and the gains to be achieved by improving its diversity. Using a strategic combination of NIH and institutional resources, the G-RISE program at CCNY has the demonstrated capacity to support an average cohort of 13 underrepresented (UR) Ph.D. trainees each year for five years, appointing each trainee for 2-3 years. A coordinated program of stimulating interdisciplinary coursework, rigorous research training, and structured activities to build research identity, ethical values, and career readiness will improve the number and proportion of underrepresented Ph.D.’s who pursue rewarding careers in the biomedical research workforce.